Defining disease mechanisms in SLC35A2 epilepsy

ABSTRACT
Many epilepsy syndromes associated with severe, early-onset seizures result from de novo variants in genes
involved in early brain development. Recent studies have also identified somatic variants in focal epilepsy
associated with cortical malformations, including hemimegalencephaly and the more common focal cortical
dysplasia (FCD) type 2. These post-zygotically acquired variants arise during neurogenesis and are therefore
present in only a fraction of cells. Expanding on these early discoveries implicating somatic variants in epilepsy,
we recently identified brain-specific somatic mutations in SLC35A2 in individuals with refractory neocortical
epilepsy. Germline variants in SLC35A2 were previously implicated in a rare X-linked developmental and
epileptic encephalopathy. Our data suggest that somatic variants in SLC35A2 may also be responsible for
approximately 17% of intractable non-lesional focal epilepsy cases. The number of cells harboring a pathogenic
SLC35A2 variant allele appears to correlate with disease severity, and several of the cases have FCD type 1a
(FCD1a) pathology. Pathogenic variants in SLC35A2, both somatic and germline, prevent the Golgi-localized
transporter from moving UDP-Galactose (UDP-Gal) into the Golgi apparatus for use in the formation of essential
galactosylated glycans. There is theoretical, experimental, and observational data suggesting that Gal
supplementation may be able to restore glycosylation to the cell to provide therapeutic benefit. In this study, we
will define the functional consequences of SLC35A2 variants in epilepsy. Given that not all cells carry the variant
allele in the individuals with a somatic SLC35A2 variant, in Aim 1 we seek to use resected human brain tissue
specimens to identify the specific cell types in the brain harboring the variant alleles. This will allow us to
determine which cell types contribute to SLC35A2 epilepsy and whether cell-type-specific burden dictates the
pathological observations. In Aim 2 we will evaluate the effects of the variants on cell-type-specific glycosylation
in human induced pluripotent stem cell (hiPSC)-derived neural progenitor cells and mature glutamatergic
neurons, a cell type that we have preliminary data to support involvement in the epileptogenic processes. Since
nearly all patients with an SLC35A2 variant have seizures, and a significant fraction has FCD1a, in Aim 3 we will
also characterize the effects of the variants on individual and neural network activity, neural migration, and
neurodevelopment in both human (e.g., hiPSC-derived neurons, 3-D organoids) and mouse models (e.g., mouse
neural progenitors and in utero electroporation). In Aims 2 and 3, we will assess the effectiveness of Gal to
restore glycosylation and reverse effects on neuronal development or activity. Collectively, these studies will
translate our exciting initial discovery implicating a novel pathway underlying a significant fraction of individuals
suffering from intractable seizures into studies of the role of glycosylation defects underlying localized brain
dysfunction in focal epilepsy. Given that the glycosylation pathway represents a potentially druggable target, this
work may inform precision medicine approaches to the treatment of refractory epilepsy.

Public health relevance
PROJECT NARRATIVE Genetic variants are typically transmitted from the parents to their offspring, but they can also arise after conception (post-zygotically acquired) during embryonic development. Genetic variants in SLC35A2 arising during brain development have recently been implicated in intractable focal epilepsy. In this study, we seek to: (1) determine the brain cell types involved in SLC35A2 epilepsy, (2) study effects of the variants on neuronal glycosylation, neuronal development, and neuronal activity, and (3) assess the ability of galactose supplementation to reverse the deleterious effects of the variants on neurons.